Synthesis, quantification and in vivo assessment of arsenolipids prevalent in seafoods

PROJECT SUMMARY / ABSTRACT
Arsenic (As) is an environmental toxin that is causally associated with increased risk of cardiovascular disease,
diabetes, neurological deficits and cancers in humans. The primary route of As exposure in humans is via diet:
food and drinking water. While the toxicological risks of exposure to As from drinking water have been well
studied, little is known about the toxicological risk of exposure to As from food sources. Addressing this data gap
is critical considering that 93% of As exposure occurs via the ingestion of food—with seafood consumption
accounting for 83.7% of that exposure. Moreover, increasing evidence suggests that chronic exposure to As, as
would be expected from the consumption of seafood, can affect cognitive-behavioral development—an
understudied, yet significant, health- and economic- consequence. Given the associated health benefits with the
consumption of seafood as a lean source of protein, and consequential predicted increase in consumption,
delineating the elimination, bioaccumulation and behavioral consequences of the ingestion of As
species common to seafood is of paramount importance. In seafoods, a large fraction of As occurs as
arsenolipids, a class of compounds which includes arseno-fatty acids (As-FA), arseno-hydrocarbons (As-HC)
and arseno-fatty alcohols (TMA-FOH). It is commonly assumed that organically-bound As species, such as As-
FAs, As-HCs, and TMA-FOHs, have no toxicological consequence. This assumption is refuted by two converging
lines of evidence. First, inorganic As is often metabolized to organic As species which are toxic. Second, As-FAs
and As-HCs have been determined in vitro to be cytotoxic and potentially neurotoxic. TMA-FOHs have received
scant attention, despite having a similar chemical structure and thus potentially similar toxicological
characteristics. To address these critical knowledge gaps, we will develop methods for the synthesis and
quantification of TMA-FOHs in biological matrices, such as organs, urine and feces. We will also characterize
the elimination profile of mice acutely exposed to representative As-FA, As-HC and TMA-FOH compounds at
varying concentrations. This evaluation will provide significant new knowledge about the potential for toxicity of
three common arsenolipids in seafood. To further disentangle this potential, we will also extend this evaluation
to mice exposed chronically to these As species. We will evaluate storage of these species in organs as well as
the health-related behavioral consequences of such exposure. Completion of this study will provide significant
new knowledge about the role of organic As species, in general, and arsenolipids, in particular, in human health
and disease, with potential consequences for the development of public health regulations.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) Humans are routinely and chronically exposed to organic As species, such as arsenolipids, in seafoods. While it is commonly assumed that organic As species have no toxicological consequence, recent work has shown that arsenolipids may be toxic to brain, bladder and liver. Understanding the toxicological risk of exposure to arsenolipids from seafood will improve our understanding of arsenic and human health and lead to the development of associated public health regulations for As in foods.